The Pediatric Biomedical Research Program

PROJECT SUMMARY
The Pediatric Biomedical Research Program at Sanford Research will provide research
experiences in pediatric biomedical science to undergraduate students in South Dakota, support
the pursuit of scientific careers, and increase diversity in the scientific community. Sanford
Research is a hub for pediatric research with a track record of student training at all levels.
Through integration of cutting-edge research experiences, career and professional development
workshops, presentation opportunities, peer mentoring, and outreach activities, we will
accomplish the following aims: I. Grow scientific career training opportunities in South Dakota by
building career pipelines and preparing students for the growing biomedical workforce; II. Expand
student exposure to the scientific workforce through interaction with scientists at all career levels,
peer mentoring opportunities, and career and professional development programming; III.
Increase diversity in the scientific community by training underrepresented students for science
careers; IV. Enhance regional community awareness of science through outreach activities aimed
at educating and inspiring community members and the next generation of scientists. With a
growing biomedical workforce demand and limited training opportunities within South Dakota, the
Pediatric Biomedical Research Program will be a vital resource to train undergraduate students
in pediatric research and prepare them for biomedical career opportunities in this dynamic and
rapidly growing region.

Public health relevance
PROJECT NARRATIVE The Pediatric Biomedical Research Program at Sanford Research will provide research experiences in pediatric biomedical science to undergraduate students in the South Dakota, a state with a rising biomedical workforce and limited undergraduate training opportunities. Through integration of cutting-edge research experiences, career and professional development workshops, presentation opportunities, peer mentoring, and outreach activities, the program will effectively grow scientific career opportunities in South Dakota, expand student exposure to the scientific workforce, increase diversity in the scientific community, and enhance regional community awareness of science.